Nucleus reuniens of the thalamus as a target for driving network-wide memory states

PROJECT SUMMARY
The primary goal of the present proposal is to explore the role of pathway-specific RE neurons in the
synchronized activity of the prefrontal-hippocampal circuit (mPFC-HC) and memory related rhythms in wake
(episodic-like sequence memory) and in sleep states (REM/NREM). To accomplish this, Aim1 will determine if
and how excitation of RE neurons can drive memory related mPFC-HC coherent states. The first experiment
will test a range of relevant frequencies in RE-pathway specific neurons to identify a stimulation capable of
driving mPFC-HC coherent modes in freely behaving rats. Using a closed-loop optogenetic approach, the
second experiment will stimulate RE neurons to induce mPFC-HC coherence during different endogenous
coherence states to boost memory performance while rats perform in a nonspatial sequence memory task. As I
transition to my independent career (R00), Aim2 will explore the role of pathway-specific RE neurons in driving
theta and delta related sleep oscillations (REM/NREM) using a closed-loop setup. Two new technical skills will
be acquired during the K99 training phase which include 1) learning to run a sophisticated rodent sequence
memory task capable of testing multiple RE-dependent memory dimensions, and 2) implementing a cutting
edge closed-loop optogenetic control system capable of detecting neurophysiological coherence modes
between the hippocampus and medial prefrontal cortex in `real-time' to trigger RE optogenetic stimulations.
My previous training in anatomy, optogenetics, multisite electrophysiological recordings, and my theoretical
background on RE-related mnemonic processes and arousal provides me with the foundation and technical
skills necessary to pursue these goals with this additional training. Florida International University, a research-
intensive and Hispanic-serving institution, is the ideal place to complete my training because it offers all the
resources (mentor, equipment, facilities, and professional development programs) necessary to carry out the
proposed experiments and training plan. The mentoring team is composed of two well-established and highly
successful scientists, who together are committed to my success and will adequately prepare me for a career
as an independent research investigator. The K99 phase of this award would allow me to enter the
independent stage of my career with the theoretical, technical, methodological, networking, and laboratory
management skills necessary to answer scientific questions at the circuit and network level, establish my own
laboratory, and independently pursue future scientific directions. As a MOSAIC awardee and future principal
investigator, one of my goals is to become a role model and mentor to other underrepresented students and
scientists, so that I can enhance diversity, equality, and inclusion in the biomedical field.
Overall, this research will shed new light on the role of RE in driving network-wide memory states, while the
training plan will equip me professionally to launch my independent career.

Public health relevance
PROJECT NARRATIVE Abnormal neural synchrony between the medial prefrontal cortex and hippocampus is a key feature of several pathophysiological and cognitive brain disorders including but not limited to schizophrenia, Alzheimer's disease, and epilepsy, thus understanding how prefrontal-hippocampal interactions are supported at the circuit level can have a significant impact on public health. Nucleus reuniens (RE) of the midline thalamus is thought to drive coherent neural states between the medial prefrontal and the hippocampus during wake and sleep states, however, this idea remains experimentally untested. The proposed research will explore the excitatory actions of RE pathway-specific neurons on the coherent activity of the prefrontal-hippocampal circuit during an episodic-like sequence memory task, and during theta and delta driven rhythms in sleep (REM/NREM) to determine how RE influences those interactions in support of memory and behavior.